Lung Allograft Stem Cell Regeneration and Immune Destruction

PROJECT SUMMARY: End-stage lung disease is the third leading cause of death worldwide. Lung
transplantation is often the only option for patients with advanced lung disease, yet 50% of recipients die within
five years due to the development of chronic lung allograft dysfunction (CLAD). This project seeks to examine
the basis for the loss of region-specific stem cells and impaired airway regeneration, with a long-term goal of
improving cell-based regenerative medicine approaches. We will make use of innovative transgenic ferret
models in our well-established orthotopic lung transplantation model. We will investigate the role of glandular
myoepithelial cells (MECs) in renewing submucosal gland (SMG) cells and generating abnormal surface basal
stem cells (BSCs) in CLAD. We hypothesize that sustained regenerative pressures drive MECs to exit their SMG
stem cell niche to reconstitute surface BSCs with abnormal lineage properties that promote an immune response.
Additionally, this project will determine the regenerative function of KRT7+ glandular duct cells (DCs) during the
progression of CLAD. We hypothesize that the gland duct is a maturation point for MEC stem cells to adopt a
surface BSCs phenotype that is bypassed under sustained regenerative stresses in CLAD. Finally, we will
determine the relationship of antigen-experienced B-cells in promoting alloimmune and autoimmune reactions
against airway stem cells to drive CLAD. We hypothesize that prolonged regeneration of surface BSCs by
reserve MEC stem cells leads to the retention of MEC proteins on the airway surface. This ectopic expression
of self-antigens promotes an autoimmune response against the SMG stem cells niche. Currently, end-stage lung
disease is a significant cause of morbidity. However, we expect that by clarifying the processes that deplete stem
cells in transplanted lungs, we will improve the likelihood of developing long-term objectives of developing
effective stem cell therapies to sustain lung function and resilience to prevent CLAD.

Public health relevance
Project Narrative: Lung transplantation is often the best remaining treatment option for patients with end-stage lung disease, but immune rejection can limit long-term survival. We must address major knowledge gaps in how airway cells are renewed in lungs after transplantation and how the recipient's immune system targets and destroys airway stem cells. Thus, there is a critical need to develop and use appropriate animal models to study the destruction of stem cells in the lung.